Outreach, Recruitment and Engagement Core

PROJECT SUMMARY/ABSTRACT: OUTREACH, RECRUITMENT & ENGAGEMENT CORE
The Outreach, Recruitment, and Engagement Core (ORE) Core of the Goizueta Alzheimer's Disease
Research Center (GADRC) at Emory University under the leadership of Monica W. Parker, MD and Cornelya
Dorbin (co-leader), will continue highly successful outreach and engagement activities supporting the needs of
the GADRC and broad priorities of the ADRC network as specified in RFA-AG-24-001.The ORE Core has
emphasized the engagement, recruitment, and retention of African American (AA) individuals in Alzheimer’s
disease (AD) and AD-related disorders (ADRD) research for over a decade. We build on a foundation of an
academic-community partnership, the Registry for Remembrance Community Coalition (RfRCC), established
in 2008.The ORE Core shares the GADRC’s central theme – discovery of new biomarkers and pathogenic
mechanisms that explain pathological and clinical heterogeneity of AD and related disorders to enable greater
precision in early identification, intervention, and, ultimately, prevention of disease – and supports GADRC and
national priorities to lead efforts expanding meaningful engagement of a diverse population of research
participants. In the next funding period, the ORE Core build on our successful Community Based Participatory
Research (CBPR) strategies and innovative approaches to: 1) sustain and promote participation by African
Americans and expand engagement of other URM communities in AD/ADRD research; 2) promote education,
outreach, and engagement activities in diverse communities and develop ethical and equitable partnerships;
and 3) partner with the Clinical and Lifestyle Empowerment Cores to disseminate educational and outreach
activities across Georgia and into clinical practice.